A novel tool to quantify hypoxia burden from clinical sleep studies

Project Summary/Abstract
Obstructive sleep apnea (OSA) affects a signiﬁcant portion of the middle-aged population in the US and
has been associated with a number of health concerns including cardiovascular disease and cognitive dys-
function. The development and progression of these health consequences is believed to be related to the
severity of OSA. However, current clinical indicators of OSA severity, which include an intermittent hypoxia
pattern at the tissues and the apnea-hypopnea index (AHI), fail to capture the impact of the consequences
associated with the disease. The intermittent hypoxia exposure pattern at the tissue-level, a qualitative
indicator of OSA severity, relies on pulse oximetry for measurement, which has limitations including inaccu-
racies in recording and only a generalized representation of systemic arterial oxygen hemoglobin saturation.
In addition, the AHI, a quantitative measure of OSA severity, has not been shown to be strongly correlated
to disease development in previous clinical studies. Accordingly, there is a large volume of OSA sleep study
data that needs to be re-analyzed. Therefore, to better understand the development of OSA-related con-
sequences, there is a need to assess OSA severity with a method that avoids the aforementioned clinical
limitations. This can be achieved with mathematical modeling and, in this project, we propose to develop
a model for a more detailed clinical representation of OSA. In Aim 1, the model will be constructed using
fundamental mass transfer equations to track the transport of oxygen and carbon dioxide throughout the
body. Considering the lack of patient-speciﬁc approaches in current OSA modeling literature, our model will
have the ability to use respiratory and heart rate data from polysomnography studies and will be feasible for
clinical application. Therefore, to address the limitations of current measures of intermittent hypoxia expo-
sure, the result of Aim 1 will be a presentation of blood gas concentration proﬁles at the arterial and venous
ends of various target tissues, which will allow for a quantiﬁcation of hypoxia burden. In Aim 2, the model
from Aim 1 will be used with clinical data to run a correlation analysis between predicted oxygen decreases
and patient daytime sleepiness, a potential indicator of OSA presentation, which could provide an alternative
to the AHI. Therefore, the two primary outcomes of this project will be a clinically deployable mathematical
model for OSA severity assessment and a large pool of data obtained from simulated cases of OSA and a
re-analysis of existing sleep studies, which will play an important role in improving patient care.

Public health relevance
Narrative Accurately assessing obstructive sleep apnea (OSA) severity is essential to improving patient care. In this proposal, we will develop a mathematical model to provide a detailed clinical representation of OSA at various target locations in the body, which will allow for the assessment of tissue hypoxia burden and daytime sleepiness as a potential alternative indicator of severity. The clinically deployable model and resulting pool of data, which will be obtained from simulated cases of OSA and a re-analysis of existing polysomnography studies, will be invaluable to furthering the clinical understanding of OSA.